Active and passive humoral immunity to enteric adenovirus infection in Bangladeshi children

PROJECT SUMMARY/ABSTRACT
Candidate: I am an Assistant Professor at the University of Virginia (UVA) in the Division of Infectious Disease
and International Health and a KL2- Funded Scholar in the Integrated Translational Health Research Institute
of Virginia (iTHRIV) Scholars Program. I have pursued research in host pathogen immune interactions with Dr.
William Petri for the past 6 years. Beginning initially with enteric pathogens and shifting to SARS-CoV-2 during
the pandemic, I will now return to my work in diarrheal disease utilizing my background in viral immunology
through study of adenovirus (AdV) 40/41 infection, a major cause of childhood diarrheal illness in low- and
middle- income countries (LMIC).
Career Development Plan/Career Goals & Objectives: My goal is to become an independent translational
investigator. I will do so by furthering my knowledge base in the design of clinical trials, host pathogen
immune interactions, viral immunology and data analysis. I will utilize my advisory committee who are not only
successfully funded researchers but have a proven track record for mentoring young physician scientists.
Research Plan: Characterize the systemic and mucosal immune response to AdV 40/41 infection in children in
Bangladesh and determine the efficacy breast milk antibodies in providing passive immunity.
Aim 1 (PASSIVE IMMUNITY): (1A) Describe the antibody repertoire to AdV 40/41 in the breast milk of mothers
of Bangladeshi children using a novel protein microarray and (1B) determine their association with infection in
the first 2 years of life. Plan: Determine maternal breast milk antibody breadth and magnitude, and test for its
association to infant infection.
Aim 2 (ACTIVE IMMUNITY): Characterize the antibody responses to AdV 40/41 infection in Bangladeshi
children and test for their association with subsequent infection utilizing longitudinal (2A) serum and (2B) stool
samples. Plan: Describe mucosal and systemic antibody scope and magnitude and test for association with
protection from subsequent infection.
Mentor/Co-Mentor(s), and Collaborator(s): The primary mentor of this K23, Dr. Petri, has a 30-year
record of NIH Funding and has mentored 10 prior K awardees, 6 of whom have already made the K to R
transition. My mentors include experts in immunology, virology, childhood diarrheal disease and statistics.
Environment and Institutional Commitment to the Candidate: The intellectual environment at UVA is robust. I
have a strong commitment from my Department and Division assuring 90% protected research time regardless
of the outcome of this K23 proposal, and support of my continued mentorship under Dr. Petri at UVA.

Public health relevance
PROJECT NARRATIVE As diarrheal disease is consistently a leading cause of morbidity and mortality in children under 5 worldwide and adenovirus (AdV) 40/41 identified as a leading cause, there is a great need for further study of this pathogen, particularly the immune response to infection. Successful completion of the proposed aims will serve as the perfect vehicle for development into an independent translational investigator, provide invaluable insight into the humoral response to adenovirus (AdV) 40/41 infection using a cohort in Bangladesh and bring us one step closer in discovering immune targets for vaccine development.